Data Management and Analysis Core

PROJECT SUMMARY: Data Management and Analysis Core
The Iowa Superfund Research Program (ISRP) tackles a highly complex issue that requires a well-integrated
thematic approach. The Data Management and Analysis Core (DMAC) will provide the expertise, tools, and
workflow optimization to support and maximize ISRP research results and impact. The DMAC and project
leaders will develop tailored Priority Analysis Plans with rigorous Quality Assurance to assure accuracy,
precision, representativeness, comparability, and reproducibility using appropriate statistical and analytical
methods. As a result, ISRP projects will make high-impact discoveries, publish in high-quality journals, and
provide timely scientific guidance to stakeholders regarding PCBs in the environment and their effect on
human health. DMAC will have five Specific Aims: 1) develop, maintain, and automate data management,
data-sharing, and quality assurance infrastructure for full reproducibility, transparency, and rigor in all ISRP
studies; 2) support ISRP projects and cores with embedded expert biostatical contributions, services, and
guidance; 3) develop novel statistical methods and associated software for data analytic challenges that impact
all ISRP projects, cores, and affiliated sciences; 4) support the Research Experience and Training
Coordination Core by providing guidance, resources, events, and instruction on data science and informatics to
trainees and investigators; and 5) provide the data management and analytical foundations for research
integration across the ISRP. Activities proposed under DMAC Specific Aim 3 address SRP mandates 2 and 3,
which call for novel statistical methods and tools to support detection and risk assessment. Activities under
Specific Aim 5 address SRP mandates 1, 2, and 4 by integrating data and methods from across the ISRP into
cost-effective solutions and strategies to comprehensively assess and reduce population-scale PCB risks to
human health. Through DMAC, the ISRP is charting new territory at the University of Iowa (UI). This work
represents a unique opportunity to align existing resources to support interdisciplinary research. With the help
of our UI partners, the DMAC will be an early adopter of proven enabling approaches and technologies for data
management, data-sharing, reproducible research workflows, and informatics investigation and training. DMAC
will lead the application of biostatistics and informatics to support and optimize ISRP research. We will provide
expert staff, platforms, policies, and research support for all ISRP projects and cores throughout the research
process, including training and methods to maximize research outcomes, applied solutions, replicable
products, and sound evidence-based decision support. DMAC’s activities will enhance full ISRP integration
and catalyze effective development, refinement, application, and sharing of innovative solutions generated by
ISRP interdisciplinary and transdisciplinary PCB research. DMAC’s centralized services, platforms, and
policies, along with innovative new methods, will yield economies of scale in effort and cost for data
management, processing, sharing, analysis, and training.

Public health relevance
PROJECT NARRATIVE: Data Management and Analysis Core The Data Management and Analysis Core (DMAC) is a proposed new core designed to support the specific data management and analysis needs of Iowa Superfund Research Program (ISRP) projects and cores. DMAC’s primary objective will be to apply biostatistics, informatics, and data management to support and optimize the ISRP scientific research process, training, and methods to maximize research outcomes, applied solutions, replicable products, and sound evidence-based decision support. DMAC will provide expert staff, infrastructure, services, software, and research support and synthesis in order to achieve these goals.